Language is Medicine: A Caregiver-Implemented Language Intervention to Prevent Developmental Delay in Dine Toddlers

PROJECT SUMMARY/ABSTRACT
Native American (NA) toddlers and preschoolers experience a high rate of preventable developmental delay
(DD) which contributes to decreased kindergarten readiness and often results in the need for special education
services. In addition, children with DD are at high risk for preventable health issues, such as obesity and
behavior problems. Varying environmental factors, such as poverty, decreased opportunities for structured
play, increased caregiver stress, and low print exposure can contribute to DD. One of the most effective ways
to address this type of DD is through caregiver coaching intended to boost the frequency of quality, language-
rich interactions between caregivers and their young children. Evidence shows DD, especially in the areas of
language and social-emotional skills, can be both prevented and remediated through increased language
nutrition (LN) exposure. LN is defined as early language exposure that is rich in quality and quantity and
delivered through social interactions at home. LN is crucial for a young child's development and strongly
associated with future literacy, academic achievement, and better health. An ideal opportunity to deliver LN
programming to NA families today is through Tribal Home Visiting programs. The “+Language is Medicine
(+LiM)” intervention that will be tested in this study combines cultural adaptations of two evidence-based
language interventions: It Takes Two to Talk and Enhanced Milieu Teaching. The current +LiM training
package equips tribal home visitors to model and coach primary caregivers through home-based education to
use responsive and reciprocal early communication and language acquisition strategies--emphasizing
traditional language learning, when possible—to support their children's development. This randomized
controlled trial intends to test the effectiveness of the +LiM intervention with caregivers and children ages 9 to
24 months living on the Navajo Nation. We will evaluate +LiM versus a beneficial control condition (Family
Spirit Nurture—which promotes optimal early childhood feeding) on preventing early childhood DD, using a
Hybrid Type I Effectiveness-Implementation approach. We will track toddler's development before, during, and
after the +LiM intervention is delivered. An additional aim is to co-design promising implementation strategies
to support integration of +LiM at scale across the Navajo Nation and other communities. This aim will be
accomplished through collaboration with +LiM participants and national stakeholders to understand barriers to
and facilitators of +LiM implementation across the country. This study is responsive to Program Announcement
PAR-20-238 and focuses on key areas of interest including the development, adaptation, and testing the
effectiveness of health-promotion and disease-prevention interventions in NA populations. Our overall
objective is to rigorously test the +LiM intervention designed to be embedded in tribal home visiting programs
so that we can detect early signs of DD in NA toddlers and prevent these delays from progressing.

Public health relevance
This randomized controlled trial aims to address the developmental delay (DD) and associated long term health outcomes in Native American communities where access to culturally competent and effective early identification and intervention for DD is limited. We aim to address this gap by testing the effectiveness of a primary and secondary prevention intervention “+Language is Medicine” that can be embedded within increasingly available tribal home visiting services. Our study is grounded in participatory processes and led by a team of Indigenous and allied researchers.